Effect of dietary restriction and exercise on behavioral outcomes and brain pathology in a transgenic model of Alzheimer's disease

PROJECT SUMMARY: HALL PROJECT
Alzheimer’s Disease (AD) is one of the most devastating diseases of our time; with nearly 6 million diagnosed
it ranks as the third leading cause of death among older adults. In the race for a cure one thing is certain—diet
and exercise reduce risks. However, the mechanisms responsible for the reduced risks are unknown. Several
studies have linked dietary restriction and exercise to improved memory, reduced amyloid beta plaques, and
tau protein tangles in AD. This project will evaluate if intermittent fasting (IF), a popular method of dietary
restriction, administered independently and in combination with exercise, is neuroprotective in a novel model of
AD, the TgF344-AD transgenic rat. The aims of this project are three-fold. 1) To characterize IF protective
effects on behavioral outcomes (memory, coordination, and strength) in the TgF344-AD rat. 2) To determine if
exercise provides additional protection when combined with IF. 3) To assess the effects of IF independent and
in combination with exercise on AD pathology and protective pathways of interest. This project will result in an
unveiling of the effect of IF in the brain and skeletal muscles tissue in the TgF344-AD animal and project could
establish a pathway of protection for future research into pharmacological treatment of this devastating
disease.

Public health relevance
PROJECT NARRATIVE: HALL PROJECT Not applicable. See Overall plan.